Identifying small molecules with selective toxicity towards muscle invasive prostate cancer cells

This project team aims to screen and develop chemical probes with differential drug sensitivity profiles of a muscle-invasive prostate cancer cell line. High throughput screening of the muscle-invasive prostate cancer cell model is a mostly unexplored phase of metastasis where aggressive cancer cells first leave their confined organ invade the surrounding smooth muscle tissue.

During this period, the team has developed a 1536-well assay to perform viability screening of the muscle invasive prostate cancer line. Several NCATS compound libraries were screened using cell viability assays to identify chemical probes that lethally and specifically target muscle-invasive prostate cancer cell lines compared to the parental and diverse prostate cancer cell models.